Modality-specific restoration of somatosensory connections after dorsal root injury

Primary somatosensory axons of the dorsal root (DR axons) relay sensory information of diverse modalities from
the periphery to the spinal cord (SC). They are commonly damaged by DR injuries, which cause permanent loss
of sensation and coordinated limb movements. The devastating consequences occur because DR axons stop
regeneration at the entrance of the SC, the dorsal root entry zone (DREZ), and because there is no therapy that
restores sensory connections even for nociception, which does not require long-distance axon regeneration past
the DREZ. Importantly, increasing evidences strongly suggest that DR axons prematurely terminate regeneration
at the DREZ by forming synapses with oligodendrocyte precursor cells (OPCs). This novel inhibitory mechanism,
which we termed ‘synaptic arrest’ by OPCs, raises the intriguing possibility that OPCs act as the major
mechanism restricting regeneration not only at the DREZ but also intraspinal regeneration of DR axons, broadly
elsewhere in the SC. Furthermore, synapse formation with OPCs may also restrict appropriate synapse
formation of sensory axons with correct SC neurons, further hampering modality-specific reinnervation and
functional recovery. In this proposal, we will address these clinically significant issues while investigating novel
therapeutically applicable strategies to overcome synaptic arrest. In addition, we will use advanced imaging and
mouse genetic tools that now permit selective investigations of physiologically distinct DR axons of specific
modalities. Aim 1 will determine if specific axon subtypes terminate regeneration primarily by OPC-mediated
synaptic arrest at the DREZ. Aim 2 will determine if BRAF/mTOR viral activation of specific axon subtypes
overcomes synaptic arrest, enabling modality-specific functional regeneration in the SC. Aim 3 will determine if
transient OPC ablation markedly enhances BRAF/mTOR-elicited intraspinal regeneration and/or reinnervation,
robustly enhancing modality-specific functional recovery. Multifaceted information gained from these studies will
fill significant gaps in current knowledge, moving the field substantially forward. Together with the unprecedented
modality-specific investigations, this information could be very useful for developing new clinical therapies to
restore specific somatosensory functions after debilitating DR injuries.

Public health relevance
Narrative Primary somatosensory axons are commonly damaged irreversibly by dorsal root injuries, causing incurable loss of sensation and coordinated movements of the muscles and limbs. Our study will address why these axons fail to regenerate into the spinal cord and how to enable them to restore appropriate sensory connections with the spinal cord neurons. Our findings will establish the foundation for new treatments that restore sensory functions to patients suffering from debilitating DR injuries.